Leadership, Planning and Evaluation

Executive Director Suresh Ramalingam, MD, provides the overall strategic direction for Winship and oversees a
rigorous planning and evaluation process. Ramalingam established a strong leadership team whose members
serve as trusted advisors and leaders to support the development and achievement of Winship's strategic goals.
During the current funding period, this team has expanded to include key experts for community outreach and
engagement (COE), and training and education (CRTEC). The Winship executive team is now composed of the
Executive Director, Deputy Director, five associate directors, five senior advisors, and two at-large positions.
Together the leadership team has led the continued growth in Winship's research programs, shared resources,
clinical research, and clinical operations. Continuous planning and evaluation efforts as implemented through
Winship's Strategic Plan have fostered growth across the cancer research enterprise with increasing numbers
of basic cancer research projects translating into investigator-initiated clinical trials, increased clinical trials
enrollment supporting the state of Georgia catchment area, and expansion of team science with successful
programmatic grant submissions including lung SPORE, P01, and a myeloma SCOR award. Winship is guided
by internal and external experts including an External Advisory Board (EAB), which is composed of a renowned
group of cancer center directors, program leaders, researchers, and administrators from other NCI-designated
cancer centers across the country. The EAB is charged to provide critical evaluation of Winship's progress on an
ongoing basis and guide the development and implementation of the strategic plan. The EAB meets annually at
Winship to review and critique Winship's progress, plans, and major decisions. In addition, Winship also engages
EAB members for input on important topics and key decisions throughout the year.